A Randomized Controlled Trial to Improve Health Insurance Literacy and Surveillance among Young Adult Cancer Survivors

ABSTRACT
The first year after cancer treatment ends is a critical time to establish survivorship care for young adult (YA)
cancer survivors ages 26 to 39. Receipt of evidence-based survivorship care, including surveillance for cancer
recurrence based on national guidelines, remain low among YA survivors. At the same time, YAs ages 26 to
39 have the highest rate of both uninsurance and underinsurance among US adults. Our team’s prior work
demonstrated that YA cancer survivors report low understanding of their health insurance and the services it
covers, which affects their ability to navigate care. Together, these issues can lead to significant access to care
barriers and severe medical cost consequences for this population. This proposal addresses the urgent need
to improve YA cancer survivors’ health insurance literacy and decrease financial toxicity, thus improving their
ability to receive recommended survivorship care. Guided by Andersen and Aday’s Behavioral Model of Health
Services Use, we developed and pilot-tested a 4-session virtual patient navigation intervention for YA cancer
survivors that was adapted from a pilot program for childhood cancer survivors. Initial results support feasibility,
acceptability, and preliminary efficacy of both of these pilot trials with YA survivors ages 26 to 39. We now
propose a randomized controlled trial to test the efficacy of this program (“CHAT-S”) to improve health
insurance literacy, financial toxicity due to medical costs, and post-treatment surveillance for recurrence among
YA cancer survivors ages 26 to 39. We plan to randomize N=300 (N=200 intervention; N=100 usual care) YAs
with breast, testicular, lymphoma, sarcoma, and colorectal cancer who have completed initial treatment within
the past year from 14 locations in the University of Utah Healthcare (UUHC) and Intermountain Healthcare (IH)
systems. UUHC and IH have many rural (20%) and Hispanic/Latinx (18%) YA cancer survivors; we will
oversample these important subgroups. We will determine whether CHAT-S improves health insurance literacy
and financial toxicity at 6-month follow-up (primary outcomes). Further, UUHC and IH have an integrated data
infrastructure which allows us to capture electronic health records and claims data to investigate whether
CHAT-S improves surveillance care for recurrence at 18-month follow-up (secondary outcome). We will
explore moderators (e.g., rurality, ethnicity) of the intervention effects. Finally, to inform future dissemination,
we will conduct a budget impact analysis and a short-term and long-term time horizon cost-effectiveness
analysis of CHAT-S. This proposal addresses the National Cancer Institute’s goal of improving the care of
cancer survivors and mitigating financial toxicity. We will demonstrate that a virtual health insurance literacy
intervention can improve insurance literacy, financial toxicity, and surveillance care among YA cancer
survivors, and provide guidance to improving survivorship care across the United States.

Public health relevance
NARRATIVE We propose a randomized controlled trial to test a 4-session virtual health insurance navigation intervention that will increase knowledge about health insurance, reduce financial burden, and improve surveillance for recurrence among 300 young adult cancer survivors ages 26 to 39. We will combine self-reported survey data with electronic health records and claims data to examine the trial outcomes and efficacy. We will also conduct an economic evaluation using cost-effectiveness and budget impact analyses, to establish the sustainability of the intervention at improving outcomes of young adult survivors through increasing their health insurance knowledge and decreasing their financial burden.